TGFBeta Receptor Mutations in Cancer and Other Diseases

DESCRIPTION (provided by applicant): Transforming Growth Factor-β (TGFβ) controls tissue homeostasis and orchestrates the response to tissue injury and repair. Cancers escape from TGFβ 's homeostatic function but can activate the tissue repair function to enhance their invasive/metastatic phenotype. This concept has led to the development of TGFβ pathway antagonists for cancer treatment. However, the absence of biomarkers for TGFβ "pathway addiction" is a major roadblock in the development of these agents for clinical use. Our central hypothesis is that TGFβ receptor gene mutations are indicative of pathway addiction and, therefore, predictive of response to antagonists. Over 40 cancer-associated missense mutations of the types I or -II TGFβ receptor genes (TGFBR1, TGFBR2) have been identified. We have recently found that some of these constitutively activate the TβR-II receptor kinase, associated with loss of Smad2/3 activation on the one hand, and with de novo activation of Smad1/5 and a highly motile and invasive phenotype on the other. Moreover, treatment with selective TβR-ll kinase inhibitors reversed the transformed phenotype. In parallel, Marfan syndrome-like genetic disorders have recently been attributed to mutations of TGFBR1 or TGFBR2. These mutations also confer an activated phenotype on patient fibroblasts and vascular smooth muscle cells. Moreover, striking parallels exist between cancer- and Marfan-like syndrome-associated TGFBR mutations: (1) TGFBR2 gene mutations are much more common than TGFBR1 mutations;(2) TGFBR2 mutations are clustered in the C-lobe of the TβR-II kinase;and (3) many of the TGFBR2 mutated in human cancers coincide with those involved in Marfan-like syndromes as well as with the TGFBR2 orthologue in D. melanogaster. Thus, converging experimental evidence from these three very different sources strongly supports the hypothesis that TGFβ receptor gene mutations can confer an aberrant activated cellular phenotype. Our specific aims are: 1. To predict the effects of TGFBR2 gene mutations on interactions with other proteins using structural biology approaches;2. To determine which TGFBR2 gene mutations confer gain-of- function phenotypes using genetic assays in D. melanogaster;3. To determine the effects of TGFBR2 gene mutations on TGFβ signaling in mammalian cells;4. To utilize selective chemical TβR kinase inhibitors to determine their potential therapeutic effects on gain-of-function TGFBR2 mutant cells. These studies are particularly important because TGFβ antagonists are in (pre)clinical development for the treatment of (metastatic) cancer as well as fibrotic disorders. Thus, not only will our studies provide a precise understanding of the molecular pathobiology of disease-causing TGFBR mutations, but they will also inform the clinical development of TGFβ pathway inhibitors for cancer and other disorders.